Data Science for Decision Support in the HIV Care Cascade

Abstract
HIV and AIDS continue to be significant public health issues, but with recent advances in treatment,
technology, clinical and social support, the research and treatment agenda now explicitly and
realistically includes bringing the decades-long pandemic to an end. The President’s Emergency Plan
for AIDS Relief (PEPFAR) is an ongoing multi-billion investment to deliver antiviral therapy to those in
low- and middle-income countries (LMIC), and has been regarded by many as the most successful public
health intervention in modern history, having dramatically reduced both prevalence and incidence of
HIV over the past two decades. With both clinical trials and observational studies conclusively
demonstrating that immediate treatment with antiretroviral therapy (ART) is the mosteffective way to
both treat HIV and prevent the transmission of new infections, retention in HIV care and suppression
of viral load through compliance with ART are arguably the most effective methods available for
bringing the pandemic to an end, and indeed are encoded in the UNAIDS 95-95-95 benchmarks of
having 95% of cases diagnosed; 95% of diagnosed cases initiated and retained on ART; and 95% of
treated individuals achieving viral suppression.
Clinical decision support systems (CDSS) tailored to the requirements of LMICs have been shown to
improve compliance with guidelines and quality of care by a range of healthcare staff. Use of machine
learning algorithms allows the development of prediction models for clinical complications and
outcomes, which can guide health care staff in early identification of problems and appropriate
interventions. The Specific Aims of this proposal therefore are (1) to use a large electronic health
record (EHR) database to develop and validate statistical machine learning models to identify patient
at high risk for loss to follow up and viral failure; (2) to develop and field test implementation of clinical
decision support tools based on these models that will be implemented at the point of care; and (3) to
evaluate the efficacy of the decision support tools, in terms of improving patient retention and reducing
viral failure, using a randomized comparison at the clinic level. Our project will be implemented at the
Academic Model Providing Access to Healthcare (AMPATH), an HIV care program in western Kenya
serving nearly 200,000 people with HIV.

Public health relevance
Project narrative Retention in care and viral suppression via antiretroviral therapy are critical for continuing progress toward global elimination of HIV. This proposal develops and evaluates data-driven clinical decision support tools that are designed to maximize retention and viral suppression by identifying patients who will benefit from proactive support and other interventions. The tools utilize data from electronic health records and are customized to low- and middle-income country settings; successful implementation will maximize patient engagement in care, further reduce HIV incidence, and enable continued progress toward worldwide elimination of HIV.